LOXORIBINE IN PATIENTS WITH ADVANCED MALIGNANCIES

This study will assess the toxicity, pharmacokinetics, immunologic effects, and clinical effects, if any, of Loxoribine in patients with advanced malignancies who have failed standard therapy. Loxoribine is a nucleoside analogue with low toxicity which is a pleiotropic agonist of immune responses in a variety of species, including man.